The Role of VEGF in the Development of Low Back Pain Following IVD Injury

Project Abstract
Low back pain afflicts up to 80% of Americans and accounts for over $100 billion in healthcare and social costs
annually. While intervertebral disc (IVD) degeneration and injury have been strongly associated with low back
pain, the causation between pathoanatomical features of the IVD and clinical presentation of low back pain
remains poorly understood. Recent rodent work show that axial low back pain symptoms can be recapitulated
by the targeted injury of the lumbar intervertebral disc. The injury evokes a degenerative sequala in the IVD
and produces neurite infiltration that are associated with chronic behavioral symptoms of axial low back pain.
This is corroborated by human studies that observed increased innervation in degenerated IVD from humans.
Thus, understanding the molecular events that drives IVD innervation may provide insights to therapeutic
opportunities prior to the transition to chronic LBP symptoms. The proliferation of sensory nerves is tightly
regulated by Nerve Growth Factor (NGF) and Vascular Endothelial Growth A (VEGFA). NGF serves critical
homeostatic functions in neurons, while VEGFA plays a crucial role in spontaneous neurite extension and
dendritic outgrowth in connective tissues, in addition to initiating angiogenesis. Degenerate and injured IVD
cells express VEGFa as a part of the inflammatory cascade, but the mechanistic effects of VEGFA on
neoinnervation in the IVD and subsequent low back pain behavior have not been investigated.
The central hypothesis of this proposal is that the ablation of VEGFA attenuates neurite growth
and vascularization into the injured IVD and alleviates ensuing low back pain symptoms. We will
investigate the hypotheses through the following specific aims: Specific Aim 1: Determine whether the deletion
of VEGFA 2-days after injury prevents IVD innervation and vascularization, and low back pain symptoms 3-
and 12- weeks following a targeted injury. Specific Aim 2: Determine whether the deletion of VEGFA 6-weeks
after injury slows, arrests, or reverses IVD innervation and vascularization, and low back pain symptoms 12-
weeks following a targeted injury.
The mechanistic understanding of VEGFA’s role in modifying the pathoanatomy will pave the way as a
disease modifying therapy for low back pain. The ease for delivery anti-VEGF therapies makes it an attractive
candidate for the diseased IVD, and anti-VEGFA has already been approved for the treatment of macular
degeneration and cancer in humans. The proof-of-concept work here will also lay the foundation for future
studies to investigate the source of VEGFA by utilizing tissue-specific drivers of CreERT2; the VEGF crosstalk
between intervertebral disc, endothelial cells, and sensory neurons; and leveraging these chronic low back
pain mechanisms as potential therapies.

Public health relevance
Project Narrative Intervertebral disc degeneration is strongly associated with low back pain, but the role of the intervertebral disc as the pain generator is not clear. We aim to investigate the role of vascular endothelial growth factor A in regulating the pathological in-growth of blood vessels and nerves in intervertebral discs during low back pain, and the molecular factors that govern the pathoanatomy. The improved understanding of these molecular events will help to develop therapies for treating low back pain.